Biology of Tie2 in sepsis

DESCRIPTION (provided by applicant): The Tie-2 receptor is highly and specifically expressed in endothelial cells. Its global constitutive activation in mature blood vessels is thought to mediate vascular quiescence. Sepsis is a common and morbid disease whose cardinal manifestations involve the vasculature. RATIONALE: Both the expression and activation of Tie-2 fall in experimental sepsis, creating a double-hit to its constitutive signalng. Stimulation of Tie-2 with recombinant Angiopoietin-1 (Angpt-1, its endogenous agonist ligand) or non-Angpt-1 peptide mimetics prevents multi-organ dysfunction and death in murine sepsis. Angpt-2, the context-dependent antagonist of Tie-2, is elevated in the circulation of septic individuals in proportion to the severity of disease, and early measurement of circulating Angpt-2 may predict adverse outcomes in patients with suspected infection. Despite these promising findings, little is understood about the direct local physiological contributions of impaired Tie-2 signaling and even less is known about the regulation of Tie-2 and its ligands in states of inflammation. HYPOTHESIS: We hypothesize that impaired Tie-2 signaling may contribute to the vascular leakage, vascular inflammation, and multi-organ dysfunction that contribute to death in sepsis. AIMS: To test this, we propose 3 aims: (1) using tissue-specific tetracycline-inducible dominant-negative Tie-2 mice to study the acute and chronic consequences of locally impaired Tie-2 signaling; (2) applying cellular and rodent models of inflammation to identify mechanisms through which Tie-2 expression is suppressed; and (3) elucidating a mechanism of inflammatory Angpt-2 induction that may be attenuated by drugs currently being evaluated in critically ill populations. RESEARCH DESIGN: To execute these parallel aims, we have designed cellular mechanistic studies that will complement state-of-the-art mouse genetic models already validated in our laboratory. These tools will provide unprecedented insights into the biology of Tie-2 through gain- and loss-of-function experiments. We have assembled a team of experts in sepsis research, rodent physiology, mouse genetic models, and Tie-2 signaling to assist us.

Public health relevance
PUBLIC HEALTH RELEVANCE: Sepsis-the body's final response to severe infections-is a top-ten cause of adult death in the United States whose incidence is increasing and for which no targeted therapies are available. Our laboratory studies a molecular pathway, the Angiopoietin-Tie-2 axis that regulates the health of blood vessels throughout the body. The current proposal seeks to understand why Tie-2 signaling is switched off in sepsis, what the exact consequences are, and how we can restore the normal Tie-2 signal to benefit patients suffering from sepsis.